Community Engagement and Outreach (CEO) Core

The vision of the Community Engagement and Outreach (CEO) Core is to develop and sustain crucial
community- academic research partnerships that enhance population health by addressing critical gaps in
health care, resources, and understanding the diverse needs of Kentucky residents. Despite existing community
outreach, engagement, and research efforts, KY lags significantly in all national health metrics, especially
among diverse and under-resourced residents. A critical need for multi-directional efforts exists to promote
awareness of and sensitivity to local health issues while ensuring community-participatory interventions
and research addresses the needs of a diverse, underserved, and under- resourced community. The
overarching goals of this core are to improve the overall health and well-being of Kentuckians by raising
awareness of community health research needs and improving access to relevant research studies and data,
while addressing the needs of at-risk subgroups, including health education, health literacy, and trust. To
accomplish these goals, the proposed project will build community trust and health literacy through health
intervention and research partnerships, using community-to-bedside prevention modalities, innovative
community-participatory research, healthcare partners, and medical advances. Our multifaceted approach
includes multi-directional information sharing in many formats, including Community Knowledge Exchange
Sessions (CKES), Stakeholder Advisory Boards (SAB), collaborative activities with other Louisville Clinical and
Translational Research Center (LCTRC) Cores, and discussions among citizen scientists, clinical investigators,
health clinics, partners, research coordinators, and physician/community liaisons. We will work to integrate
cultural respect and sensitivity throughout the design, implementation, and dissemination of community-
participatory research. These activities will provide a base for strategic partnerships and study participants for
clinical and translational (C&T) research geared toward mitigating health disparities. We will leverage our
team’s breadth and depth of experience in community outreach and engagement and C&T research to address
the following Aims:
Specific Aim 1: Promote understanding of community health/research needs and disseminate
knowledge, health research education, and share C&T research and resources with target communities.
Specific Aim 2: Develop and support community-led and clinical investigator-initiated community-based
participatory research.
Impact: The CEO Core, in concert with stakeholders, will invest in both community-led and community-
participatory C&T research to prevent, manage, and treat chronic diseases using multi-directional inputs that are
sensitive to the culture and needs of our underserved target audience.